Decoding the Mechanical Interactions between Tissue Layers Sculping Organ Shape

Project Summary
[The project summary remains as described in the original application.]
Organ shape is vital for proper function. Malformations in the looping and folding of the heart, for
instance, represent the leading cause of birth defect mortality in humans. Visceral organs rely
on the coordinated activity of multiple laminar tissue layers to fold and coil into targeted shapes.
While the community has learned much about the genetic signals governing cell fates during
development, less is understood about the mechanical stresses and tissue dynamics that
translate gene expression into the shapes of organs. This proposal aims to understand the
connection between Hox patterning and mechanical stresses driving organ folding and
rotational torques driving organ looping using the D. melanogaster midgut as a model system.
The midgut begins as a tube of two concentric tissue layers that undergoes a sequence of
constrictions to fold into chambers. Advances in light-sheet microscopy now enable live
visualization of the whole organ at cellular resolution during development. During the K99
period, we integrated these imaging methods with physics approaches to follow cell dynamics
across tissue layers across the whole organ throughout morphogenesis (see K99 phase
publications). This technology enables us to quantitatively relate genetic patterning in the tissue
to the tissue mechanics and dynamic cellular behaviors driving 3D shape change.
During the R00 phase, I am leveraging the tools developed during the K99 phase for three aims.
First, we will decode the relationship between Hox gene patterning and the downstream pattern
of calcium pulses in the midgut using quantitative measurements in WT and mutant embryos.
The second aim, which builds on these results, will address the role of the endoderm in driving
tissue folding, with particular attention to the role of the Hox gene labial. The final aim,
performed in parallel with the others, addresses how the midgut coils into a chiral tube at later
stages of development. Recent discoveries have shown that ‘cell intrinsic’ chirality, in which
cytoskeletal machinery breaks left-right symmetry, plays a key role in determining organ-scale
chirality. The mechanical process by which cell chirality translates into 3D organ-scale shape
change, however, remains largely unknown. By combining the in toto imaging toolkit, molecular
tools learned during the K99 phase, and my expertise in chiral mechanics from my PhD, this
aim will link cellular chirality to the dynamics of organ-scale coiling.

Public health relevance
Project Narrative During development, genetic patterning instructs tissues to form complex shapes that are crucial for proper function. Using whole-organ live imaging and approaches from physics, this study will analyze how gene expression patterns and cell-scale chirality govern tissue-scale mechanical forces to sculpt a visceral organ, using the midgut of the embryonic fly as a model system. This study may provide fundamental insights into the roles of calcium signaling and cell chirality in the processes driving healthy organ formation, with ramifications for congenital diseases such as heterotaxy.